Separating the molecular determinants that govern the evolution of Orthoflavivirus NS5-mediated IFN antagonism

PROJECT SUMMARY
Flaviviruses infect up to hundreds of millions of people worldwide annually. The spectrum of diseases caused
by these viruses display a range of symptoms from mild illness to hemorrhagic fever, encephalitis, and congenital
defects. To establish infection and cause pathogenesis, viruses need to suppress their vertebrate host’s innate
immune response. Flaviviruses use their non-structural protein 5 (NS5) to suppress type I interferon (IFN)
signaling. While this function is highly conserved, there is diversity in the host factors that are targeted. ZIKV,
DENV, and YFV NS5s target signal transducer and activator of transcription 2 (STAT2) for
degradation/sequestration. These flaviviruses are transmitted by Aedes mosquitoes and circulate in a sylvatic
cycle between non-human primates and humans. TBEV, LIV, and LGTV NS5s target tyrosine kinase 2 (TYK2)
to inhibit its catalytic activity. These viruses are tick-borne and mainly circulate in rodents, with humans acting
as dead-end hosts. TBEV, LGTV, and WNV NS5s target prolidase (PEPD) to block the expression of IFNAR1
on the cell surface. WNV, transmitted by Culex mosquitoes, circulates in birds with humans acting as dead-end
hosts. These findings suggest that some flaviviruses evolved NS5s that encode multiple modes of IFN
antagonism. While tick-borne flaviviruses and Culex-borne flaviviruses primarily amplify in rodents and birds
respectively, their host ranges are much broader. Perhaps this extended host range applied variable evolutionary
pressures that resulted in diverse modes of antagonism. My proposal will expand the knowledge of NS5-
mediated IFN antagonism evolution and provide a framework for categorizing these mechanisms. I will achieve
these goals by testing my central hypothesis that the evolution of flaviviruses is constrained by the structural and
molecular determinants that govern their IFN antagonism functions in essential reservoir vertebrate hosts. In
Aim 1, I will use structure-function analyses to identify determinants that define each mode of NS5-mediated
IFN antagonism. Cryo-EM and extensive mutagenesis will serve to create a molecular “fingerprint” for each
mechanism that will be used to screen a range of flavivirus NS5s to identify their mode of antagonism. I will
explore the overlap in antagonism and replication determinants by conducting multicycle growth curves of
various NS5 mutants in vitro, since not only is NS5 evolutionarily restricted by its function in innate immune
suppression but also in the replication of the RNA genome. In Aim 2, I will examine the coevolution of type I IFN
signaling in vertebrate hosts and flavivirus NS5. On the viral side, chimeric NS5s that swap regions from
flaviviruses with divergent antagonism mechanisms will be tested for both host factor interaction and antagonism
capabilities to. On the host side, I will replace endogenous PEPD and TYK2 with orthologs of various vertebrate
species and study the ability of various flavivirus NS5s to antagonize these proteins. Together, the proposed
work will provide a broader understanding of flavivirus NS5-mediated antagonism both in distinct structural,
molecular terms, as well as provide clues about the evolutionary history as well as potential of these viruses.

Public health relevance
PROJECT NARRATIVE Flaviviruses that pose significant public health threats are those that evolved to successfully block their host’s innate immune response while not sacrificing viral replication function. The proposed research will investigate the structural and functional determinants that govern flaviviruses ability to utilize various modes of non-structural protein 5 (NS5)-mediated interferon (IFN) antagonism as well as their evolution. Therefore, this work will provide important information about not only potential sites in NS5 that could serve as drug targets or create attenuated viruses to use in vaccine strategies, but also clues about the evolutionary potential of emerging flaviviruses.